ABCD-USA Consortium: Coordinating Center

PROJECT SUMMARY
Supplemental funds are requested to continue achieving three key objectives of the ABCD Study: dissemination,
resource sharing, and comprehensive genomic analysis.
To accomplish this, the ABCD consortium will contract a professional communications vendor to perform the
following services: generating engaging and accurate information for different audiences in various forms,
developing materials (e.g., flyers, cards, newsletters, infographics), including graphic design; supporting social
media, including content creation and managing an interactive forum; foreign language translation of all materials
into Spanish to accommodate Spanish monolingual participants and families; providing support for meeting and
event logistics, including webinars for families and the general public, while also targeting different research
communities; conducting audience research/focus groups (as needed) to guide the development of new
assessment elements and acceptability of materials for various groups seeking information about the study
results; and implementing retention campaigns through channels such as outreach and social media (as needed)
to bolster retention.
Additional funds are also necessary for the continued support of biorepository functions currently provided by
the Altman Clinical and Translational Research Institute (ACTRI) for maintaining a Biobank for salivary fluid
samples and shed deciduous teeth contributed by ABCD participants. Funding is requested for: ACTRI staff
effort; lab supplies, including tubes for aliquoting, freezer boxes, and biosafety materials; shipping of the samples
to ACTRI; secure storage for saliva samples, housed in three to four secure, monitored freezers, and secure dry
storage for teeth; a dedicated cold-empty freezer for emergency use; daily physical monitoring of all freezers,
24-hour electronic monitoring, and fault notification capabilities; a license fee for FreezerWorks software for
sample tracking, management, and freezer inventory; and the development of an API to allow ACTRI to access
the NBDC Portal. Funding is also requested to replace centrifuges at all sites with new refrigerated centrifuges
to reduce the incidence of poor quality when aliquoting serum samples.
Lastly, funding is also requested for whole genome sequencing and quality control of sequencing data for
remaining unsequenced participants in the cohort, as well as confirmatory testing (through CLIA-certified service)
and provision of genetic counseling to individuals who meet criteria for pathogenic medically actionable
secondary findings. Genetic counseling will also be offered to individuals who may need additional information
to decide whether to consent to receive their results.

Public health relevance
PROJECT NARRATIVE This work will enhance the value and impact of a large study of children and adolescents by increasing the amount and quality of information provided to the public about the results of the study, by assembling and sharing with researchers valuable biospecimens contributed by study participants, and by acquiring comprehensive genetic information obtained from new analyses to achieve cross-cutting scientific discoveries for improving long- term health outcomes in developing youth.